Evolution of 3D Genome Folding Mechanisms and Gene Regulatory Strategies in Metazoans

Evolution of 3D Genome Folding Mechanisms and Gene Regulatory Strategies in Metazoans
Abstract:
The overarching goal of this project is to elucidate the role that 3D genome folding plays in shaping transcriptional
regulatory strategies in animals. It has been proposed that organisms use multiple mechanisms, notably loop
extrusion and phase separation, to fold nuclear DNA into a variety of structures including compartments and
topologically associating domains (TADs). These features have been shown to have functional consequences
on the transcriptional regulation of genes. As 3D features differ between lineages and have different regulatory
properties, it is likely that changes to 3D folding mechanisms could have profound consequences on the
transcriptional regulation strategies used in distinct lineages. Despite rapid progress, largely driven by
development of chromosomal conformation capture techniques, in identifying the mechanisms of genome folding
in major animal model organisms such as flies, nematodes and mouse, several barriers exist to our broader
understanding of the relationship between evolution of 3D genome folding and evolution of transcriptional
regulatory strategies including 1) 3D genome studies cover only a fraction of the diversity of animal genomes
and many critical transitional lineages are not sampled 2) 3D genome maps generated by HiC represent an
averaged view of the interplay between several co-existing mechanisms, making it challenging to link specific
transcriptional processes to 3D architecture and disentangle their contribution to gene regulation. To overcome
these challenges, we will employ a novel phylogenetic comparative approach using chromatin technologies,
functional genetics and single-cell approaches to 1) generate 3D genome maps in outgroups to the vertebrates
and to the Bilateria using approaches we have established in non-model marine invertebrates 2) functionally
assay the role of chromatin-interacting proteins we have isolated from these lineages to determine the
mechanistic basis of changes to genome folding 3) characterize the transcriptional regulatory strategies used in
these animals via approaches we have developed to study gene regulatory mechanisms. This work will generate
a fuller view of the evolution of 3D genome folding mechanisms in animals and will provide insight into the global
drivers that shape gene regulatory strategies, which ultimately form the basis of changes to body plan complexity
and phenotypic evolution. Furthermore, by contributing to our understanding of the basic mechanisms that
shape 3D genome folding and gene regulation, insight generated through this comparative work will better inform
our understanding of the dysregulation of gene expression that occurs in pathological contexts in humans such
as cancer. The flexibility and perspective of the MIRA is ideally suited to support this integrated, multi-faceted
program whereby rapidly evolving technologies can be readily integrated into the scope of this research program
over the next five years.

Public health relevance
Project Narrative Gene expression is mediated by the activity of non-coding cis-regulatory elements, enhancers and repressors, that control the spatial and temporal context and level of transcription. Work in vertebrates has identified a causal relationship between the 3D folding of the genome into discrete territories and the control of gene regulation – disruption of 3D architecture results in aberrant gene regulation leading to dysgenesis and cancer. Using comparative and functional approaches, this project will investigate when 3D structures including TADs and factories emerged in animals and the role that 3D architecture plays in the establishment of cell fate, the progression of development, and, over evolutionary timescales, the generation of novel phenotypes.